Investigation of Drug-Drug and Drug-Circuit Interactions in Children on Continuous Renal Replacement Therapy

PROJECT SUMMARY/ABSTRACT
Continuous renal replacement therapy (CRRT), a form of dialysis, is life saving for children with acute kidney
injury. Despite this, children supported with CRRT are at still at high risk for death, with mortality rates
exceeding 40%. This high mortality is thought to result in part from altered drug exposure. Altered drug
exposure occurs from 1) drug-drug interactions due to the administration of multiple drugs; 2) multi-organ
dysfunction; and 3) direct drug interaction and/or removal of drug by the CRRT circuit. As a result, for most
drugs, optimal dosing in children on CRRT is unknown.
The goal of this study is to determine optimal dosing of 5 commonly used drugs in children on CRRT. In AIM 1
we will determine how drugs interact with the CRRT machines by injecting five drugs singly and together into
isolated, closed-loop CRRT circuits. In AIM 2 we will build physiologically based pharmacokinetic (PBPK)
models to predict optimal drug dosing in children. PBPK models are computational models in which the body is
represented as a set of virtual organ compartments linked by blood flow. Mathematical equations characterize
changes in drug concentrations as the drug passes through the virtual organs. These mechanistic models can
account for the impact of physiologic covariates such as age and disease and incorporate the impact of drug-
drug interactions. Importantly, we can use the data from AIM 1 to build a CRRT “organ” in the PBPK model to
account for the impact of CRRT on drug dosing. Finally in AIM 3 we will collect prospective drug concentration
data from children who are on CRRT and one or more of the selected drugs. We will compare the observed
concentration data from these children with the PBPK model-predicted concentration data in order to refine
and validate the PBPK model. We will use the final PBPK model to predict optimal dosing under different
scenarios such as drug co-administration and different CRRT settings.
This study will determine the PK of common medications and interactions between drugs co-administered in
children on CRRT. Results can be directly translated to the bedside and improve safety and effectiveness of
drugs used in critically ill children on CRRT. Training will take place at the University of Utah under the
mentorship of a leading expert in PBPK modeling. Through my training plan, I will develop the necessary skills
for a career as an independent research scientist including the necessary technical skillset, completing
coursework in pharmacology/pharmacokinetics, and the effective communication of data and results.

Public health relevance
PROJECT NARRATIVE This study will determine the pharmacokinetics, drug-drug interactions, and drug-circuit interactions of commonly used drugs in children on CRRT both ex vivo and in vivo. I will use PBPK modeling to translate the ex vivo results into bedside dosing recommendations and evaluate model predictions using the in vivo data. The proposed research will transform pediatric drug development in critically ill children on CRRT by combining translational and clinical research to advance our knowledge of the underlying mechanisms of drug action, response, and safety.